Ceramides as novel drivers of metabolic dysfunction and colorectal cancer

Summary
Diet-induced obesity affects about 40 percent of US women and increases the incidence, morbidity, and mortality
of postmenopausal breast cancer (BC). Obesity also increases the risk of large, high-grade tumors, metastasis,
and recurrence regardless of menopausal status. Our goal is to contribute to the development of new therapeutic
approaches for the treatment of obesity-associated human BC. Our research proposal addresses this by testing
whether dietary lipids induce the biosynthesis of ceramides which accelerate BC tumor growth. Supported by
published evidence and our own preliminary data, our central hypothesis is that, in settings of chronic dietary
lipid overabundance such as obesity, BC cells are wired to utilize free fatty acids (FFA) over glucose to support
cancer lipid anabolism, resulting in accelerated tumor growth. Moreover, our data suggests that ceramides
dictate this fuel choice by serving as feed-forward signals of fatty acid excess that increase fat utilization and
decrease carbohydrate oxidation. We will test our central hypothesis by pursuing two specific aims: 1) to test the
hypothesis that ceramide-lowering interventions negate the impact of ketogenic diets or apolipoprotein E
knockout on breast cancer growth; 2) to determine whether experimental induction of ceramides alters fuel
choice and accelerates breast cancer growth. Our approach, which collectively addresses physiology, adipose
biology, and tumor metabolism, is enabled by our combined expertise in ceramides (Dr. Summers), nutrition and
metabolic status (Dr. Chaix), adipose tissue biology (Dr. Hilgendorf), and in vivo stable isotope tracing to study
tumor metabolism (Dr. Ducker). Together, we have established a system in which BC tumor growth can be
accelerated solely by the manipulation of circulating levels of lipids, independent of adiposity and associated
metabolic syndrome. This lipid-centric view of tumor metabolism generates strong testable hypotheses for future
therapeutic interventions, including the one described herein that ceramides are obligate intermediates that link
excessive saturated fats to worsened breast cancer outcomes.

Public health relevance
Narrative Individuals with obesity face a heightened risk of developing breast cancer. Our proposed research will test whether ceramides increase breast cancer growth and whether ceramide-lowering interventions might be suitable for these patients. Thus, the proposed research is of high relevance to public health and perfectly aligns with NCI mission to support cancer research by advancing scientific knowledge and helping people live longer, healthier lives.